Risk of Care Escalation after Non-Pharmacologic Treatment: Leveraging Real World Physical Therapy Data

ABTRACT
Musculoskeletal pain is a highly prevalent, costly, and burdensome condition commonly managed with opioids.
Opioids do not often adequately address pain and have high risk for misuse and addiction. As a result, clinical
practice guidelines strongly recommend non-pharmacologic treatments for musculoskeletal pain. Physical
therapists are one of the most common providers of non-pharmacologic pain care in the US. However up to
43% of people receiving non-pharmacologic treatments delivered by physical therapists continue to seek care
for their pain condition beyond the physical therapy episode, signaling a sub-optimal response to non-
pharmacologic treatment. Additional treatments received often are higher risk, more invasive, and not
recommended by current practice guidelines (e.g., opioids, surgery). The overarching aim of this project is to
use real-world data to better understand risk factors for poor response to non-pharmacologic care delivered by
physical therapists. This knowledge will enhance individual treatment decision making (e.g.., when to consider
coordinated multimodal care) and provide direction on how to re-design non-pharmacologic care models to
better address risk for poor response. In Aim 1, we will identify baseline factors associated with an unfavorable
change in pain-related disability (a common precursor to escalation of care) among patients undergoing
treatment by a physical therapist. Using the ATI Outcomes Registry Dataset, one of the largest outcomes
datasets specific to physical therapy, we will derive common trajectories of self-reported disability following
initiation of care (Sub-Aim 1a) and develop multivariable models to identify risk factors for an unfavorable
disability change trajectory (Sub-Aim 1b). Aim 2 will use a separate, large claims-based dataset comprised of
industrial union workers to identify baseline factors associated with escalation of care (i.e., subsequent use of
imaging, opioids, injection, and surgery) following initiation of treatment by a physical therapist for
musculoskeletal pain (Sub-Aim 2a). Sub-Aim 2b will use a subset of the claims-based dataset that is also
included in the ATI Outcomes Registry to determine the incremental change in probability of care escalation
associated with each one-point improvement in disability score. This information could help clinicians set
disability improvement targets for a meaningful reduction in risk for escalating care. In exploratory analyses, we
will assess how the mass disruption of healthcare delivery related to COVID-19 impacts these questions. We
will perform stratified analyses for each Aim to 1) determine whether disability trajectories and factors
associated with those trajectories have changed following the onset of COVID-19, and 2) establish whether
receiving physical therapy prior to or after onset of COVID-19 is associated with differences in risk for poor
outcomes. Collectively, this work aims to improve the delivery of non-pharmacologic care in an effort to reduce
risk for opioid use and better address the substantial personal and societal impact of musculoskeletal pain.

Public health relevance
PROJECT NARRATIVE Clinical practice guidelines strongly recommend non-pharmacologic care for musculoskeletal pain but not all patients benefit from these treatments. In this project, we will use two large real-world datasets to identify risk factors for poor response to non-pharmacologic care delivered by physical therapists – defined as 1) an unfavorable trajectory of pain-related disability, or 2) escalation of care to imaging, opioids, injection, or surgery following initiation of care. The overarching goal of this work is to provide direction on how to improve treatment decision-making and redesign non-pharmacologic care models to reduce risk for poor response.